Functional Properties of Neural Circuits for Vision

Project Summary
For sensory systems, feedforward projections from thalamic relay cells provide the cortex with information about
the external environment. The cortex, in turn, sends extensive feedback to the thalamus. The cortex thus
functions both to process information supplied by the thalamus as well as to influence dynamically the
transmission of thalamic input. The primary goal of the experiments presented in this proposal is to determine
how the primary visual cortex (V1) and the lateral geniculate nucleus (LGN) of the thalamus interact to
dynamically influence visual processing. The study involves four sets of experiments. The first major series of
experiments (Specific Aim 1) will determine the functional topography of corticogeniculate feedback to the LGN
and will test the hypothesis that there is a center/surround organization of feedback with a central region
providing net excitation and a surround providing net suppression. The second series of experiments (Specific
Aim 2) will determine the influence of corticogeniculate feedback in augmenting extraclassical surround
suppression in the LGN and will reveal whether effects of feedback are specific for feedforward channels to
cortex. The third series of experiments (Specific Aim 3) will test the hypothesis that corticogeniculate feedback
serves to modulate retinogeniculate communication and to transform visual signals en route from retina to cortex.
The final series of experiments (Specific Aim 4) will uncover the interactions between corticogeniculate feedback
and visual attention and will determine whether attentional demand adjusts the dynamics of feedback effects on
visual signals relayed from thalamus to cortex. Given the central importance of corticothalamic pathways for
governing the excitability of thalamocortical networks, it is important that we understand the functional properties
of the corticothalamic pathway, as disorders of the pathway likely underlie several illnesses affecting vision and
visual processing.

Public health relevance
Project Narrative A reciprocal arrangement of neuronal connections governs the excitability of neurons in the thalamus and cerebral cortex. Given the severe financial and quality-of-life consequences that follow from disruption in the ability of these brain regions to communicate with each other, such as occurs with many forms of epilepsy and several illnesses affecting vision and visual processing, it is important that we gain a better understanding of their functional relationship. The goal of this proposal is to determine how the cortex and thalamus interact to dynamically influence visual processing.